Proteomics Core

Proteomics Core - Abstract
The DDRCC Proteomics Core proposes to provide DDRCC members with cutting edge proteomics to support
the Centers thematic areas. It will provide equipment and technical support to run LC-MS/MS based proteomic
methods for the analysis of post-translational modifications, protein interactions, and protein expression.
Importantly, it will be one of a handful of facilities throughout the world that provides Mass Spec Imaging
approaches to identify and characterize cellular proteins and extracellular matrix proteins in situ. The core has
extended these beyond protein identification to facilitate in situ Mass Spec Imaging of metabolites, lipids,
glycolipids, and glycans in normal and diseased tissues. The Core will adopt rigorous multi-partite evaluation
processes to ensure that it performs optimally and provides DDRCC members access to new technologies as
they are developed. Drs. Drake and Ball, who are the core's leaders, are experts in proteomic analyses. Dr.
Drake has developed much of the technology that is used in Mass Spec Imaging and Dr. Ball has an extensive
track record in the application of MALDI Mass Spec in the analyses of proteins and post-translational
modifications. Based on our polling of the DDRCC members, we expect this core to by highly utilized.